Mississippi site (Mississippi ECHO ISPCTN-2 (MS-CTN2)

PROJECT SUMMARY
The University of Mississippi Medical Center (UMMC), Children’s of Mississippi, and the UMMC Department of
Pediatrics are seeking to continue to be a site for the ECHO Institutional Development Award (IDeA) States
Pediatric Clinical Trials Network-2 (ISPCTN-2). Our site, the Mississippi ECHO ISPCTN-2 (MS-CTN2) has
made considerable progress with implementation of the initial ISPCTN fuding in 2016, greatly expanding our
institutional infrastructure and opening 2 pediatric trials: Vitamin D Supplementation in Children with Obesity-
Related Asthma and the Pharmacokinetics of Understudied Drugs Administered to Children Per Standard of
Care study.
The UMMC site’s overarching objectives are:
1. Build upon previous Network success and further enhance of our UMMC pediatric clinical research team to
reliably conduct Network pediatric clinical trials;
2. Promote engagement in pediatric clinical trials across largely rural and underserved communities;
3. Make substantive contributions to the NIH’s ECHO program that inform the health of future generations of
children; and
4. Broaden faculty, staff, and institutional capacity-building infrastructure for engagement in Network trials.
Our ISPCTN site has increased readiness for pediatric trials through increasing pediatric infrastructure
supports during the initial funding cycle. The capacity of our site has grown considerably through ISPCTN
provided trainings, collaborations with other sites, and institutional collaboration with the Mississippi Center for
Clinical and Translational Research (MCCTR). Our team has gained experience in trial recruitment and will
continue to build capacity for recruitment in rural communities during ISPCTN-2. Site investigators at UMMC
have made important contributions to the ISPCTN program, leading working groups and developing a pediatric
trial. Scholarly work products have grown through collaborations established within the ISPCTN.
With MS-CTN2, our site will continue to be fully engaged with ECHO ISPCTN trials, including those that seek
to improve care for infants exposed to opioids in utero. With ISPCTN-2 we expect to develop, implement and
complete 3 clinical trials that address ECHO disease priorities. In addition, our junior faculty will develop a
research protocol that informs an IPSCTN-2 multi-center trial. Finally, our site is leading a proposal to test an
already empirically validated psychosocial intervention, extending this intervention to high risk infants and
across rural communities, representing a novel extension to an existing intervention.
Our MS-CTN2 site is poised to become a major pediatric research center in the rural and medically
underserved communities of the deep South. With continued support our site will contribute new data from
trials that extend into rural communities, thus increasing the generalizability from pediatric trials research.

Public health relevance
PROJECT NARRATIVE The ECHO IDeA States Pediatric Clinical Trials Network-2 (ISPCTN-2) seeks to develop research that closes gaps that exist in maternal, infant, and child health, seeking to reduce rates of preterm birth and infant mortality by increasing access to pediatric clinical trials in rural and underserved communities. The Mississippi ECHO ISPCTN-2 (MS-CTN2) project provides a vital pediatric research resource in rural and medically underserved communities in the deep South. MS-CTN2 creates access for historically disenfranchised pediatric populations to participate in multisite pediatric trials and, in turn, these children and their families contribute to findings that inform the health of all children.